Improving Substance Use Disorder Treatment Experiences and Outcomes for Autistic Adults using SkillFlix Video-based Microskills Training

ABSTRACT:
The rates of diagnosed Autism Spectrum Disorder (ASD) have steadily increased in the U.S. One
in 36 children was diagnosed with ASD in 2020 and ASD affects 9 million people. While it has historically been
assumed that those with ASD were less likely to experience substance use disorder (SUD), recent studies have
shown the frequency of SUD in those with ASD as high as 36%. A large registry study of 27,000 autistic youth
and adults found that the odds of SUD in those with ASD were 3.2 times higher than non-ASD controls, with
odds increasing to 7.2 times higher for those with co-occurring ASD and ADHD. Despite the increased incidence
of SUD, those providing SUD treatment do not typically screen for ASD at even the most basic level of asking if
someone is autistic and, if it is disclosed, do not provide specific accommodations or modification of treatment
protocols. In addition, autistic individuals are often less skilled in advocating for their treatment needs or
articulating their discomfort with certain treatment modalities or need for supports. These can range from simple
requests (e.g., turning off florescent lights) to refusing in-patient treatment in favor of outpatient treatment to
minimize disruption to daily routines. To address these challenges, this project will develop a series of
demonstrative Microskills training videos (modeling videos of 30-120 seconds) designed to improve the
communication skills of those working in SUD treatment with a particular focus on autistic clients. This will include
communication during intake and treatment as well as knowledge-based content on accommodations and
approaches addressing the support needs of autistic clients. Those with ASD experience more health related
social needs than the overall population and that can negatively impact their SUD treatment and ongoing success
due to stigma, unemployment, higher poverty levels, transportation challenges, and ongoing healthcare needs.
To address these challenges the project, in Phase II, will also create video delivered skills training for autistic
adults to advocate for their needs with SUD treatment providers and get needed support for health-related social
needs. This dual approach – training providers to screen for, adjust communication, and make modifications for
autistic clients and advocacy training for autistic adults—is expected to increase support and improve outcomes
for autistic adults seeking treatment for SUD. The Phase I project will develop a prototype of SkillFlix ASD:
Improving Substance Use Disorder Treatment Experiences and Outcomes for Autistic Adults using SkillFlix
Video-based Microskills Training. Phase I development will: 1) utilize a team of expert advisors, including autistic
adults who have been through the SUD treatment and recovery process; 2) conduct formative research through
focus groups, interviews, and UX research; 3) develop and refine the SkillFlix video education platform; 4)
develop content and complete video production for 20 Microskills training videos; and 5) conduct a small study
to assess the resource’s effectiveness in changing SUD treatment staff members demonstrated communication
skills, confidence, and knowledge in working with autistic clients.

Public health relevance
PROJECT NARRATIVE Autism Spectrum Disorder (ASD) affects 9 million people in the United States. Rates of Substance Use Disorder are higher for those with ASD than the general population, with estimates as high as 36% of those with ASD experiencing substance use disorder. Despite as many as 20% of clients demonstrating signs of autism most substance use disorder treatment centers do not screen for ASD or make accommodations when treating clients with ASD. In addition, those with ASD have higher Health Related Social Needs—and those with high levels of HRSN have poorer outcomes related to Substance Use Disorder. There is an extraordinary need for Substance Use Disorder assessment and treatment tailored to this population, and corresponding supports for health related social needs, needs that are higher in those with ASD than in the general population. In response to this need the project will develop SkillFlix ASD. This innovative resource is a streaming video library, in which short videos are viewed at the user’s own pace in the order chosen, designed to develop Microskills among Substance Use Disorder staff to assist them in communicating with clients who have ASD, including screening and providing supports for HRSN, and making accommodations for those with ASD to improve their SUD treatment experience and improve the likelihood of retention in treatment. The ultimate goal being to improve long-term outcomes for Substance Use Disorder recovery for those with ASD.